Novel Polymer Additives for Infection Control Intravenous Catheters

Project Summary
Central line-associated bloodstream infections (CLABSIs) cost the healthcare system around $2 billion annually
with an estimated >80,000 incidents each year in US intensive care units (ICUs). That is not surprising with over
5 million central venous catheters (CVCs) used annually in the United States and an estimated 27 million units
sold globally. Most CVC-associated infections are caused by microorganisms introduced from patient skin during
catheter insertion. These microorganisms can also get into the lumen during manipulation and attach to device
surfaces, enhance biofilm growth and complications and result in infections.
Currently, there are two main approaches to reducing CVC-related infections either (1) adding antimicrobial
functionality or (2) adding antifouling functionality. Our approach combines antifouling and antimicrobial killing
functionalities to prevent catheter-associated infections and thrombosis into a new polymer additive product
(HaloAddTM) that catheter manufacturers can blend with thermoplastic polyurethane (TPU). We are aware of no
other similar approach that combines antimicrobial agents with anti-inflammatory and/or anti-adhesion agents to
address the complex problem of CLABSI.
This Phase I effort is geared towards answering basic performance, safety, and efficacy issues. We propose to
optimize polymer blending parameters to develop HaloAdd-modified PU material with maximum antimicrobial
and antifouling efficacy without impacting critical mechanical properties, determine in vitro anti-thrombin and anti-
biofilm properties, and verify the biocompatibility and stability of HaloAdd-blended PU for the CVC application.

Public health relevance
Project Narrative Central venous catheters provide lifesaving therapy to millions of patients every year; however, thrombosis and infection complications are high and associated with device failure, increased healthcare costs, patient morbidity, and mortality. Our novel approach is to combine antifouling and antimicrobial killing functionalities into a new polymer additive product (HaloAddTM) that catheter manufacturers can blend with thermoplastic polyurethane to prevent catheter-associated infections and thrombosis. This cost-effective and simple approach will have a meaningful impact on the safety and quality of life of patients who require a catheter by minimizing complications without using systemic anticoagulation and antibiotic treatments that will greatly decrease healthcare costs.